IKE Kapuna (Elder Wisdom) Project

RESEARCH PROJECT 2: ABSTRACT
The prevalence of Alzheimer’s disease and related dementias (ADRD) is rising in Hawai`i, where it is projected
that 10% of people aged 65+ will be diagnosed with ADRD by 2025. Nationwide, Native Hawaiians and Pacific
Islanders (NHPIs) are more likely to have early-onset ADRD than Whites, Asians, and African Americans. NHPIs
have a higher prevalence of hypertension, obesity, diabetes, and dyslipidemia than other US racial and ethnic
groups, which increase the likelihood of ADRD. ADRD is often preceded by subjective cognitive impairment and
mild cognitive impairment, which offers an opportunity for early intervention to prevent or delay ADRD onset.
Interventions that promote physical activity, healthy diet, and social and cognitive activities can prevent or slow
cognitive decline. Notably, dancing can preserve or improve cognitive functioning and neuroimaging parameters,
while reducing vascular risk factors. However, very few studies have tailored a dance program for ADRD
prevention for racial or ethnic minorities, and none have included NHPIs. We completed a randomized controlled
trial of an intervention featuring Hula in 277 NHPIs with uncontrolled hypertension. Over 6 months, the
intervention lowered systolic (-5.4 mmHg, p = 0.02) and diastolic (-4.4 mmHg, p = 0.01) blood pressure
compared to the control condition. We therefore will partner with 5 community-based organizations in Hawai‘i to
adapt our existing Hula intervention and test its effectiveness for improving vascular health and maintaining or
improving cognitive function in NHPI elders at high risk of ADRD. The ‘IKE Kupuna (Elder Wisdom) Project will
use qualitative methods to revise our existing 12-month Hula curriculum for hypertension with culturally informed
dietary education, cognitive exercises, and social engagement strategies. We will then conduct a pragmatic
group-randomized trial with 208 NHPIs aged 50-75 years with at least 1 of 4 modifiable vascular risk factors for
ADRD (hypertension, hyperglycemia, obesity, or dyslipidemia) and either SCI or MCI using a wait-list control
design. The primary outcomes will be vascular risk factors for ADRD and subjective cognitive complaints.
Secondary outcomes will include measures of cognitive performance, physical function, and mental health. We
will also collect biospecimens from all participants to evaluate the cross-sectional association between APOE
genotype, vascular risk factors, and cognitive complaints and function. Our Specific Aims are to: 1) Adapt our
existing Hula-based intervention to target vascular risk factors for dementia, improve cognitive symptoms or
function, and optimize salience, implementation, and adherence in NHPIs with subjective cognitive impairment
or mild cognitive impairment; 2) Conduct a group randomized trial to test the effect of ‘IKE Kupuna on vascular
risk factors for ADRD and cognitive complaints and function over 12 months; and 3) Evaluate the cross-sectional
association of vascular risk factors and APOE genotype with cognitive complaints and function. The NHPI elder
population is increasing and their needs are escalating. This will be the first study to test a novel intervention to
address ADRD in NHPIs and to assess the association APOE-ε4 genotype with cognitive function in this group.